Systematic investigation of genetic contributions of sex chromosomes to Alzheimer's disease

PROJECT SUMMARY
Sex chromosomes have long been excluded in genetic and genomic research of human diseases, partially due
to the technical challenges of analyzing the data from large-scale molecular profiling methods, such as next-
generation sequencing (NGS). Yet their contributions are significantly implicated in the sex dimorphism of
Alzheimer’s disease (AD). In this project, the team will apply a sex-chromosome-completement aware alignment
approach to re-align large amounts of NGS data from large clinical cohorts of AD, for systematically investigating
the genetic contributions of sex chromosomes to AD. Variants will be called based on the realignments, and both
X and Y chromosomes will be specifically investigated for the variants’ associations with AD phenotypes. The
team will also consider the contributions of the homologous X-Y gene pairs to gene expression and perform
gene network analysis to evaluate how the expressions affect sex differences in AD. The reprocessed data will
be disseminated to the public for broad use to benefit the scientific community. Taken together, the work will lay
the foundation for determining the genetic components of sex chromosomes to AD and pave the way for future
in-depth study of these genomic features and their implication in sexual dimorphism in AD.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) impacts millions of US populations, especially women, yet the molecular mechanism behind the sex differences remains poorly understood. This study aims to specifically study the genetic contributions of the sex chromosomes to the observed sex disparities in AD, which will build a benchmark of the molecular mechanism driving sex differences in AD and greatly facilitate untangling the genetic contributions from other factors in its etiology.